Biophysics and Cell Biology of Meso-scale Gap Closure

PROJECT SUMMARY
Background: Gap closure is a critical step in wound healing and the maintenance of tissue homeostasis during
embryogenesis. Current studies of gap closure focus on epithelial cells with strong adhesion strength and
junctional actin cytoskeletons and have identified lamellipodia-mediated cell crawling and “purse-string”-like
contractile actin rings as two major mechanisms for gap closure. At the molecular level, ERK and p53 activations
are known to regulate the migration and proliferation of tissues. Recent new findings, including our own data,
suggest that tissue fluidity, the tissue mechanical property that reflects the frequency of cell intercalations, plays
a major role in gap closure. It is still unclear how tissue fluidity is patterned spatiotemporally during gap closure,
how it is regulated within the cells and by the microenvironment, and what are its molecular regulators. We have
discovered that by introducing epithelial-mesenchymal transition (EMT) to epithelial cells and generating a meso-
scale gap in the order of magnitude of millimeter, tissues with partial EMT status demonstrate a coordinated
collective migration pattern that is distinct from both random cell crawling and purse-string-like contraction. This
coordinated gap closure will serve as a novel model system to study the fundamental mechanisms for gap
closure from biophysics, cell and molecular biology perspectives.
Recent Progress by the PI: In the past 7 years, the PI has established his lab and built a productive research
team at UMass Amherst. Since joining UMass, the PI’s group has published 26 journal articles and engaged 8
graduate students, 2 postdoctoral fellows, and more than 20 undergraduate researchers with diverse
backgrounds, including bioengineering, molecular and cell biology, neuroscience, and biophysics. With strong
collaborations with cell biologists, biophysicists, and bioinformatic experts, the PI’s lab has developed several
bioengineering tools to define cell microenvironment, including micropatterning, traction force microscopy, DNA-
based fluorescence sensors for intercellular force measuring, mechanical strain gradient generation device, and
single cell RNA sequencing expertise. Leveraging those tools, the PI’s lab has investigated how mechanical
cues such as geometrical confinement, substrate mechanics, and external mechanical strains regulate cell
rearrangement and migration.
Overview of Future Research Plans: To fully understand the mechanism of this novel gap closure process,
our first goal is to track and rigorously characterize cell kinematics, proliferation/growth pattern, force distribution,
and tissue fluidity during the gap closure of tissues undergoing EMT. We will study how force and tissue fluidity
patterns are regulated by environmental factors such as gap geometry, 3D curvature, extracellular matrix
properties, and external mechanical strains. Further, we aim to combine spatial transcriptomics and molecular
biology techniques to identify the molecular mechanisms for coordinated gap closure and molecular regulators
of tissue fluidity. Together, those fundamental studies will deepen our understanding of the wound healing
process and guide the design of novel medical devices to accelerate the wound healing process.

Public health relevance
Narrative This project will focus on understanding the fundamental mechanisms of tissues closing millimeter-size gaps, which is important for embryo development, regeneration, and wound healing. The proposed work will develop new tools to measure physical parameters and identify key biomolecules that are involved in such processes for various tissue types under different environmental stimuli.